Enhancing T and B cell responses to Plasmodium infection and vaccination via IL-15

PROJECT SUMMARY/ABSTRACT
Malaria, which results from infection with Plasmodium parasites, is a significant global health problem
with nearly 250 million clinical cases and over 600,000 deaths annually worldwide. With growing anti-malarial
drug and insecticide resistance, new therapeutic strategies and highly effective vaccines are urgently needed.
Protection against symptomatic disease develops after years of repeated exposures to Plasmodium parasites.
However, there is no definitive evidence of long-lived, sterilizing immunity in humans following repeated
exposure to Plasmodium parasites, and clinical immunity to malaria rapidly wanes in the absence of re-
infection. Similarly, the limited protection offered by the most advanced malaria vaccines lose efficacy quickly
in malaria endemic areas. Dysregulated inflammation is thought to contribute to the short-lived response to
Plasmodium. The cellular processes impairing the acquisition and maintenance of cellular and humoral
immunity to Plasmodium are not known. Therapies that boost the robustness and durability of the immune
response could be transformative in vaccine development. This project centers on investigating an IL-15
cytokine-based therapy that enhances the immune response to Plasmodium infection and vaccination.
The proposed studies will utilize novel peptide:MHC class II and B cell tetramers in experimental
Plasmodium infection and vaccination mouse models. We found that in the context of Plasmodium infection in
mice, IL-15 therapy promotes the differentiation of T follicular helper (Tfh) cells, which are critical for promoting
long-lived and high-quality antibody responses. In the context of whole sporozoite Plasmodium vaccination, IL-
15 therapy increases the number of liver-resident CD8 T memory (Trm) cells and antibody levels, suggesting
that IL-15 could be harnessed as an adjuvant to enhance Plasmodium vaccine immunogenicity. In this
proposal, we will define the mechanism by which IL-15 therapy promotes Tfh differentiation as well as germinal
center formation and antibody generation in the context of Plasmodium infection using novel conditional
knockout mouse models and our novel tetramer reagents (Aim 1). We will also define the impact of IL-15
therapy as a vaccine adjuvant to enhance CD8 T cell responses as well as CD4 T cell and B cell/antibody
responses to a whole sporozoite Plasmodium vaccine (Aim 2). These studies will define the mechanistic
pathways induced by IL-15 treatment that enhance Plasmodium control to both understand the disease more
completely and develop therapies that exploit these pathways. Overall, these studies will deliver foundational
knowledge of the naturally-acquired and vaccine-elicited immune response to Plasmodium. This information
will be leveraged for the rational design of vaccination strategies to improve anti-Plasmodium immunity.

Public health relevance
PROJECT NARRATIVE Malaria, which is caused by Plasmodium parasites, remains a major global health problem with over 600,000 deaths annually worldwide. Our incomplete understanding of the mechanisms underlying the slow acquisition of immunity to malaria has hindered efforts to prevent and treat it. This project investigates the effects of an immune-modulatory therapy on the T cell, B cell, and antibody responses to Plasmodium infection and vaccination.